The impact of Wnt signaling on hematopoietic stem cell aging and its influence on fracture repair

The impact of Wnt signaling on hematopoietic stem cell aging and its influence on fracture repair
Tuyet Nguyen
[email]
Alman Laboratory
Duke University
Abstract
Age-related fractures are a current problem with a high mortality rate and, as the United States aged
population increases, will become a necessary problem to address in the near future. In order to find solutions
for this impending dilemma, it is crucial to understand how bone heals and how this process changes with age.
Under homeostatic conditions, bone health is maintained through dynamic relationships mediated in part by the
Wnt signaling pathway, especially so during a fracture injury. Wnt signaling is also a known regulator in
maintaining hematopoietic stem cells (HSCs) quality, but the role that HSCs play during a fracture injury has not
been well explored. The bone marrow environment and the cells that make up the endosteal and perivascular
niches are known to be important for postnatal HSC maintenance. However, during a fracture injury, both niches
are disordered, and bone regeneration must proceed properly for the re-establishment of the microenvironment
to restore the proper cellular HSC regulatory mechanisms. Our lab and others have shown that Wnt signaling is
tightly regulated during the fracture healing process and that these signaling patterns become dysregulated with
age. Nonetheless, it remains unclear how fracture injury- and age-specific changes to the Wnt pathway affect
HSC differentiation and how this relationship in turn regulates fracture healing. This proposed work intends to
address the gap in understanding of how HSCs affect the bone fracture repair process to develop better targeted
therapeutics that best decrease fracture-related complications.

Public health relevance
Project Narrative Precise regulation of the Wnt signaling pathway is necessary to maintain hematopoietic stem cell (HSC) maintenance and quiescence. After a fracture event, the bone marrow environment, where the HSC niche resides, is then disordered and recruits various inflammatory cytokines as part of the healing process. Injury and age can lead to a dysregulation of Wnt signaling which this proposal hypothesizes alters HSC localization and differentiation, affecting the quality of fracture repair, and thus can be an unexplored target to treat age-related fracture complications.